Enhancing Primary Care Residency Training in Specialized and Individualized Patient Care

The project will now focus on developing and implementing a comprehensive curriculum for
Family Medicine residents centered on managing complex clinical needs in a patient-centered
and individualized manner. The revised curriculum removes identity-based framing and instead
emphasizes clinical preparedness, medical accuracy, and respectful care delivery in specialized
care contexts. The program will also include the establishment of a Specialized Care Program within the residency clinic, offering core and elective clinical training experiences designed to reinforce didactic learning with practical exposure to complex patient care scenarios.

Public health relevance
The result will be a scalable, adaptable curriculum package to support residency programs nationwide in meeting evolving healthcare training needs.